New Mexico Department of Agriculture Maintenance of the Animal Food Regulatory Program Standards.

PROJECT ABSTRACT
As per DHHS participating Organization U.S. Food and Drug Administration, Funding
Opportunity Number (FON): PAR-25-003, Funding Opportunity Title:
Animal Food Regulatory Program Standards Implementation Development and
Maintenance, with Mutual Reliance Initiatives Clinical Trials Not Allowed. A PROJECT
ABSTRACT is not required.

Public health relevance
TITLE: New Mexico Department of Agriculture Maintenance of the Animal Food Regulatory Program Standards PROJECT NARRATIVE The New Mexico Department of Agriculture (NMDA) Feed, Seed, and Fertilizer (FSF) Section seeks continued support to maintain full implementation of the Animal Food Regulatory Program Standards (AFRPS), ensuring alignment with national feed safety efforts. Participation in AFRPS strengthens New Mexico’s regulatory framework, enhances collaboration with FDA and state partners, and supports an integrated national food safety system. NMDA will sustain AFRPS implementation through institutionalized policies, ongoing quality management, targeted staff development, risk-based inspections, stakeholder engagement, and alignment with FDA procedures. Key objectives include maintaining full conformance with AFRPS, contributing to national program improvements, responding to Laboratory Flexible Funding Model (LFFM) sample findings, and advancing the internal auditing system in accordance with FDA’s SMG-8076. Planned activities include FDA collaboration, national committee participation, sample response coordination, audit development, and staff training. Outcomes will be measured through performance metrics, internal evaluations, and FDA assessments. This project will build lasting program capacity, ensure regulatory consistency, and protect the integrity of the U.S. animal food supply.